SAFETY OF RHGH IN UNTREATED PATIENTS WITH GROWTH HORMONE DEFICIENCY

The goal is to demonstrate the safety and effectiveness of recombinant human growth hormone (rhGH) in the treatment of growth failure due to GH deficiency. These patients will receive rhGH. The efficacy and toxicity of GH will be studied.